Examination of Elm1, polarity, and endocytosis for regulation of cellular morphogenesis in budding yeast

Project Summary Abstract
The functionality of specific cells in multicellular organisms are linked to the specific morphologies that those
cells adopt. Extensive regulatory networks including polarization, cytoskeletal dynamics, exo- and endocytic
membrane trafficking, and cell cycle control must be spatially and temporally controlled to ensure that
proliferation and cell division occur in a stereotypical fashion. Errors in properly establishing and maintaining
cellular morphologies drive cellular pathologies including many cancers, developmental disorders, and
neurodegenerative diseases such as Alzheimer’s. With so many different cellular processes being involved, the
coordination between and among them has remained elusive and represents a fundamental question in cellular
morphogenesis control. Due to the simplicity of the model organism Saccharomyces cerevisiae, the processes
outlined above have been extensively studied and are directly homologous to those in higher eukaryotes. One
of the major regulations of cellular morphogenesis in budding yeast is the morphogenesis checkpoint composed
of the sequential recruitment of the kinases Elm1 and Hsl1 and a methyltransferase Hsl7 that serves as a scaffold
at the bud neck (i.e., site of cell division) to sequester the mitotic CDK inhibitor Swe1 for proteosome-mediated
degradation. The degradation of Swe1 then allows cell cycle progression, thereby linking the mitotic cycle with
the formation of a bud after genome duplication. Recent data that only active Elm1 can lead to the recruitment
of both Hsl1 and Hsl7, along with preliminary global phosphoproteomic and fluorescent microscopy data that
Elm1 regulates polarity factors and endocytosis leads to the hypothesis that Elm1 can directly regulate Hsl7 (in
addition to Hsl1 as previously known) (Aim 1) and has expanded roles in synergy with the Cdc42 effector Ste20
and the early endocytic protein Ede1 to control cellular morphogenesis (Aim 2). Both these potential regulated
effectors of Elm1 are known to play roles in cell shape control and exhibited extensive differential phosphorylation
when compared between wild-type cells and cells deleted for the ELM1 gene. The proposed study will employ
an integrative approach including gene editing, live cell imaging, and biochemistry to illustrate the regulatory
capacity of Elm1 on the hypothesized pathways. This study will impact the understanding of the complexities
involved with cellular morphogenesis control and will fill a critical knowledge gap that can give insights important
to human health and development.

Public health relevance
Project Narrative Regulation of cell shape is critical for the normal development of organisms, however the complexities of multicellular organisms have made understanding the mechanisms of cellular morphogenesis difficult. Using an integrative approach of gene editing, live-cell imaging, and biochemistry in the budding yeast model system, this study aims to improve our understanding of these mechanisms. With errors in cell shape linked to developmental disorders and cancers, insights of this study are relevant to human health.